Synchronization of Drosophila Circadian Rhythms by temperature cycles

DESCRIPTION (provided by applicant): Our environment constantly affects our behavior. The circadian pacemaker is one of the best-characterized interfaces that connect complex behaviors with the environment. It helps most organisms to anticipate and adapt to the changes occurring every day in their surrounding. We are beginning to have a good sense of how these self-sustained rhythms function, but their synchronization is still poorly understood. This is a critical question, since improperly synchronized circadian rhythms would be of no use or even detrimental to the survival of an organism or to human health. Light input pathways have been recently studied in detail, but much less attention has been given to temperature input pathways, even though these inputs play a central role for circadian rhythm synchronization in many organisms. We propose to study temperature synchronization of the Drosophila pacemaker to answer three fundamental questions using a combination of genetic, molecular and behavioral approaches. In aim 1 we will determine how temperature synchronizes circadian behavior and identify the neuronal structures necessary for this synchronization. With aim 2 we will study genetically the mechanisms underlying the temperature input pathway. In aim 3 we will determine how the circadian pacemaker responds to temperature cycle at a molecular level. Our work should reveal novel mechanisms underlying a fundamental property of circadian rhythms: their synchronization with the environment. This should ultimately result in a better understanding of the ailments associated with improper circadian rhythm synchronizations, such as jet lag, seasonal affective disorder, and desynchronization due to shift work. PUBLIC HEALTH RELEVANCE: Circadian clocks time the physiology and behavior of most animals on a daily basis. We will study how temperature cycles synchronize the circadian clock of the model organism Drosophila to understand the general principles governing the synchronization of circadian rhythms with the day/night cycles. Since the mechanisms generating circadian rhythms are remarkably conserved in the animal kingdom, our work should ultimately contribute to the design of therapies aimed at alleviating ailments associated with abnormal synchronization of the human circadian clock, such as jet lag and mood disorders.